HIV BRAIN BANK

Well characterized brains have great utility in studies of HIV neuropathogenesis and studies relating to adequate treatment of viral reservoirs. The Manhattan HIV Brain Bank will utilize pre-extant bank infrastructure located at the Mount Sinai School of Medicine (MSSM), and coordinate patient resources at MSSM, Beth Israel Medical Center (BIMC), and St. Luke's-Roosevelt Hospital Center (SLRHC), three of New York City's largest medical complexes, to: 1. Identify and follow a well- characterized cohort with advanced HIV disease, using neurologic, neuropsychologic, medical, and laboratory examinations; 2. Establish a multi-institutional database in which clinical data are recorded; 3. Obtain autopsy-derived central nervous system (CNS), peripheral nervous system (PNS) and systemic tissues from these patients within 24 hours of their demise; 4. Provide complete pathologic diagnoses of these tissues that will be maintained in a separate but interactive pathology database; 4. Dissect, store, catalogue and distribute these tissues to extramural investigators; 5. Evaluate the appropriateness of tissue requests with a bank review committee that will function under the guidelines of the Network Steering Committee; and 6. Utilize the pathology and clinical databases in correlational studies to elucidate the pathogenesis and natural history of HIV-related neurologic diseases. Within the context of the Manhattan HIV Brain Bank, we will establish a nationwide resource for the provision of numerous well-characterized brains and tissues for study, and additionally, establish a multi- institutional longitudinal clinical/neurologic and neuropsychiatric database that will serve as a template for following a significant proportion of the medically-serviced, HIV-infected population of New York City, and assist in future studies of HIV neuropathogenesis.